Leveraging prenatal tolerance to improve AAV/bNAb therapy outcomes in infancy

PROJECT SUMMARY
Despite significant progress in HIV testing and vertical transmission prevention programs, over 100,000
children are still infected annually, predominantly in sub-Saharan Africa. Several factors contribute to this high
burden of pediatric HIV infections in the region, including inadequate healthcare infrastructure, limited access to
clinics, maternal infections during pregnancy, and stigma. Additionally, high rates of unplanned pregnancies
among women living with HIV, many of whom struggle with antiretroviral therapy adherence, complicate efforts
to eliminate pediatric HIV. While breastfeeding is a major route of vertical HIV transmission, it is also a pillar of
child survival in Africa, so a key challenge in developing pediatric HIV interventions is ensuring safer
breastfeeding for at-risk infants in a way that is practical, discreet, and does not require strict adherence to
treatment. Passive immunization with broadly neutralizing antibodies (bNAbs) offers promise for preventing
pediatric HIV infections. However, the current approach, which relies on repeated infusions of recombinant bNAb
proteins, is both expensive and difficult to implement in resource-limited settings. A potentially transformative
alternative is adeno-associated virus (AAV)-mediated gene transfer, which enables continuous in vivo production
of bNAbs by host cells, thereby eliminating the need for repeated dosing. This strategy is particularly attractive
due to the excellent safety profile of AAV vectors and their ability to transduce long-lived cells, such as myocytes,
allowing for durable bNAb expression. Consistent with the phenomenon of neonatal tolerance, we recently
identified the first four weeks after birth as an optimal window for achieving high and sustained bNAb expression
in infant rhesus macaques (RhMs) following AAV/bNAb therapy. Beyond this period, the effectiveness of the
therapy diminishes significantly as infants develop the ability to mount humoral immune responses against the
AAV-delivered bNAb (also known as anti-drug antibodies, or ADAs) that reduce or shut down transgene
expression. To extend the 4-week window for effective AAV/bNAb therapy, we sought ways to prevent ADAs in
infants treated beyond the neonatal stage. We discovered that RhMs exposed in utero to a recombinant form of
the same bNAb delivered by AAV did not mount ADAs after postnatal AAV/bNAb treatment, even when the vector
was given at 3 months of age. However, this effect waned by 8 months, at which point treatment outcomes
became indistinguishable between prenatally exposed and bNAb-naïve RhMs. Thus, the immunological program
responsible for prenatally induced tolerance to the AAV-delivered bNAb appears to be “switched off” at some
point between 3 and 8 months of age. Based on these data, this project seeks to elucidate the mechanism of in
utero bNAb tolerization in primates (Aim 1) and prolong bNAb tolerance throughout infancy (Aim 2). Ultimately,
our goal is for a one-time administration of AAV/bNAb vectors to generate long-lasting (possibly lifelong) HIV
immunity in children of all ages.

Public health relevance
PROJECT NARRATIVE Adeno-associated virus (AAV)-vectored delivery of HIV-1 broadly neutralizing antibodies (bNAbs) offers the potential for broad, potent, and long-lasting HIV immunity from a single intramuscular administration, providing a practical and discreet way to prevent vertical HIV transmission through breastfeeding in high-prevalence regions. This proposal aims to explore both basic and applied research to induce immunological tolerance to AAV-delivered bNAbs, thereby suppressing host immune responses against the bNAb. If successful, this application could pave the way for new therapeutic strategies to enhance HIV immunotherapies, prevent allograft rejection, and treat autoimmune diseases.